High-Intensity Interval Training to Recover Walking Post-Stroke: HIT-Stroke Trial 2

PROJECT SUMMARY / ABSTRACT
Among the 7 million stroke survivors living in the U.S., fewer than 10% have adequate walking speed and
endurance to complete normal daily activities like grocery shopping, which leads to a loss of life roles. Stroke
rehabilitation guidelines recommend moderate-intensity aerobic training (MAT) via walking exercise to address
this limitation in walking capacity. However, recent evidence suggests that MAT may have negligible effects
among many people in the chronic phase of stroke (>6 months post stroke), especially those with severe gait
impairment (speed <0.4 m/s). There is growing belief that a more vigorous training intensity (>60% heart rate
reserve vs 40-60%) may be critical for eliciting greater improvements in walking capacity. Yet, the optimal
training intensity has been difficult to determine among stroke survivors because neurologic impairments make
it challenging to reach vigorous intensity. This study will use a novel training protocol to overcome this
limitation. Based on the well-tested exercise science and cardiac rehabilitation strategy of high-intensity
interval training (HIT), this protocol uses bursts of maximum speed walking alternating with recovery periods, to
sustain higher intensities than physiologically possible with continuous exercise and with less perceived
exertion. Preliminary results suggest that this innovative locomotor HIT protocol may improve walking capacity
and other outcomes significantly more than MAT, and that it could be uniquely effective among patients with
severe gait impairment, a subgroup that has not yet shown meaningful responses to MAT or other
interventions. However, no previous studies have been large enough to test whether a more vigorous training
program like HIT increases benefit more than risk, yields sustained gains in walking capacity beyond the end of
training or elicits significantly greater improvement than moderate-intensity training among patients with severe
gait impairment. In this study, 156 people at least 6 months post-stroke at 3 research sites across the U.S. will
be randomized to perform either a HIT or MAT program, each involving 45 minutes of walking exercise with a
physical therapist, 3 times per week for 12 weeks. Walking function, fatigue, aerobic capacity, and quality of life
will be assessed by blinded raters at baseline, after 4, 8 and 12 weeks of training and 3 months after training
ends, while safety will be monitored throughout. The primary statistical analysis will then determine which
training intensity is better (vigorous or moderate) for safely producing meaningful and sustained improvements
in walking capacity in chronic stroke. A second analysis will also assess whether vigorous training intensity is
particularly critical for patients with severe gait impairment. At study completion, we expect to have gained
foundational knowledge about how to select training intensity to maximize recovery of walking function after
stroke. This new knowledge will likely lead to better outcomes in future studies and clinical rehabilitation, thus
making a positive impact on the disability burden of stroke.

Public health relevance
PROJECT NARRATIVE Even after rehabilitation, few stroke survivors are able to walk fast and long enough to complete normal daily activities, and poor aerobic fitness is a major barrier to recovery. This proposal will test a promising new rehabilitation strategy called high-intensity interval training that has the potential to yield greater improvements in walking function and aerobic fitness in less time than currently available methods.